UCLA IDDRC: Administrative Core

ADMIN CORE- ABSTRACT
The primary aim of the Administration, Education and Dissemination Core (Core A) of the UCLA IDDRC is to
support the overall mission of the Center by providing scientific leadership, oversight and evaluation of core
services, and an efficient centralized infrastructure, to create an environment that is optimized for conducting
outstanding research into Intellectual and Developmental Disabilities. The Core is divided into three main
functional units: Scientific Leadership, Education and Dissemination, and Administrative Support. With input from
an integrated Scientific Advisory Board, the Executive Committee of the Core will set the scientific priorities of
the Center, conceptualize and help develop new research directions and provide opportunities for a
multidisciplinary group of investigators to interact. The leadership team will set priorities for Core funding and
utilization, evaluate cost effectiveness and core quality. The Core will support trainees and early stage
investigators by creating a wide range of educational opportunities within the university, emphasizing
translational research, and in partnership with the other West Coast IDDRCs, develop technical workshops and
research symposia to provide excellent training in translational research. The core will organize mechanisms for
dissemination of research findings to the broad community, and will emphasize minority outreach, and will build
ties with stakeholders and advocacy groups. Finally, the Core will serve as the administrative hub for scientific
support and resource oversight. It will coordinate and oversee core utilization, quality assessment and cost
efficiency, liaison activities, and provide financial management, administrative and logistical functions for faculty
and students.